Integrative Neurodevelopmental Approach to CVI: Screening and Subtyping in Early Childhood

PROJECT SUMMARY/ABSTRACT
Cerebral visual impairment (CVI) is the leading cause of visual impairment occurring early in life;
however, it often remains undiagnosed until preschool age or later. This is problematic because
vision is the primary sense used for incidental and intentional learning to build foundational
motor, language, and cognitive skills leaving undiagnosed children with a disadvantage. The
proposed research aims to (1) develop a screening algorithm for early detection of CVI and (2)
establish neurodevelopmental profiles that will inform intervention for children diagnosed with
CVI. Our overarching hypothesis is that early detection of CVI and understanding the
relationship between visual impairment and neurodevelopment are imperative for informing
interventions to optimize a child’s abilities. In our first aim, we will test a novel comprehensive
screening algorithm for CVI detection in infants at three developmental time points between 4-
12 months corrected age. In our second aim, we will utilize an interdisciplinary standardized
assessment protocol including visual and developmental assessments at two-time points to
understand neurodevelopmental subtypes in young children with CVI. This proposal will be
carried out by an interdisciplinary research team with a well-established track record of clinical
practice and research in CVI. This ground-breaking proposal will lead to a paradigm shift in the
current approach to CVI management in young children. The findings from this study will lead
to the development of a screening protocol for early detection of CVI that can be easily
incorporated into practice by medical providers who routinely interact with young infants.
Additionally, identifying neurodevelopmental profiles will be the foundation for the
establishment of clinical guidelines for the care of young children with CVI.

Public health relevance
PROJECT NARRATIVE Cerebral visual impairment (CVI) is the most common cause of pediatric visual impairment and negatively impacts how motor, language, and cognitive skills develop. This study proposes to (1) establish a novel and easy to use CVI screening algorithm for infants and (2) describe CVI subtypes based on vision, motor, language, and cognition. This study will lead to earlier identification of CVI and will deepen our understanding of how CVI affects development. The results will fundamentally change the approach to designing treatments for children with CVI.